Mechanisms and Immune consequences of atypical efferocytosis of neutrophils during Porphyromonas gingivalis infection.

PROJECT SUMMARY/ABSTRACT
Neutrophils recruited to the sites of bacterial infection or inflammation eventually undergo apoptosis and are
cleared in situ by phagocytic cells such as macrophages. ‘Efferocytosis’ or the phagocytic uptake of apoptotic
cells (AC), is a highly selective process that relies upon the recognition of apoptosis associated ligands, such
as phosphatidylserine (PS), by efferocytic receptors on the engulfing cells. These interactions initiate
downstream signaling that shuts down inflammatory pathways and orchestrates the hydrolytic breakdown of
ACs within phagosomes/efferosomes for their eventual clearance. Several pathogens can manipulate
efferocytosis in order to subvert immune clearance. We found that the periodontal pathogen Porphyromonas
gingivalis uses a novel mechanism to dysregulate efferocytosis by causing the uptake of live neutrophils in a
PS independent manner, possibly bypassing engagement and/or activation of PS binding efferocytic receptors.
Our preliminary data show that this atypical efferocytosis of live cells resulted in sustained production of pro-
inflammatory cytokines and a profound failure of macrophages to activate pro-resolution pathways. We
hypothesize that P. gingivalis mediated atypical efferocytosis perpetuates inflammation in periodontal disease
and breakdown of immune tolerance. In Aim 1 of this proposal, we will delineate specific signaling pathways
that mechanistically link ingestion of live neutrophils to the generation of proinflammatory cytokines. In Aim 2
of this proposal, we will determine whether ingestion of live neutrophils results in degradation delays due to
incomplete maturation of the efferosomes, resulting in diminished hydrolytic capacity. Defects in clearance of
ACs within efferosomes is increasingly linked to chronic inflammation and autoinflammatory sequalae in a
large number of diseases. Overall, the data generated from this grant will not only shed mechanistic insights
atypical efferocytosis caused by a P. gingivalis but will also be useful in designing new therapeutic approaches
to abate chronic inflammation associated with periodontitis. Furthermore, this application includes a
comprehensive training plan that will enable me to strengthen my ability to define scientific questions and
answer them using the strong technical skillset and conceptual understanding. I will continue to expand my
expertise in areas of host-pathogen interactions, innate immune responses, and cellular signaling pathways
and the knowledge and skill sets gained from the proposed training will be invaluable moving forward as I
pursue a career as an independent investigator.

Public health relevance
NARRATIVE Periodontal diseases are highly prevalent oral inflammatory diseases that cause the destruction of tooth- supporting structures and enhance susceptibility to several chronic inflammatory and autoimmune disorders. In the proposed studies, we will determine how the oral pathogen Porphyromonas gingivalis dysregulates clearance of dying cells, leading to persistent inflammation. Understanding these mechanisms will provide opportunities for designing novel therapeutic targets in the treatment of periodontal diseases.